Dynamics of the Bacterial Ribosome and Proteome

PROJECT SUMMARY
This application describes broadly based biophysical characterization of two important aspects
of bacterial cell physiology. First, the dynamics of the entire E. coli proteome will be quantified
as a function of growth rate and nutrient limitation, including measurement of protein turnover.
The set of bacterial proteins are carefully controlled to optimize the fitness and growth of
bacteria under a wide variety of conditions. The amount of protein devoted to various
biosynthetic pathway varies in a defined way that can be simply modeled as an economic
allocation problem. Second, the process of ribosome assembly will be investigated using
electron microscopy, mass spectrometry, single molecule fluorescence, and light microscopy.
Electron microscopy of intermediates that accumulate under perturbed conditions reveals a
distribution of structures that can be ordered into a putative assembly pathway. Single molecule
fluorescence allows the monitoring of individual steps in the complex assembly process.
Finally, we will extend the in vitro studies toward studying the ultrastructure of the locus of
ribosome assembly in cells, using a combination of light microscopy and cryo-electron
tomography. The overall goal is to develop a complete mechanistic framework for assembly of
the largest cellular machine, that is responsible for all protein synthesis, and that requires
almost a third of the energy budget for a rapidly dividing cell.

Public health relevance
PROJECT NARRATIVE This grant application describes broadly based biophysical characterization of two important aspects of bacterial cell physiology. First, we will investigate the macroeconomic principles of proteome allocation by bacteria in response to different environmental challenges. Second, we will investigate the assembly of bacterial ribosomes, which is a key cellular process to produce the macromolecular machine that synthesizes all proteins in the cell.